Spatial and Temporal Tracking of Neural Stem Cells Migration to Brain Metastases of Breast Cancer using High Resolution Imaging

PROJECT SUMMARY
Patients diagnosed with breast cancer brain metastases (BM) have a poor prognosis, and their
therapeutic options are minimal. Surgical intervention is limited to a single lesion, whereas most women present
with multiple metastases, and most chemotherapeutic drugs are not effective due to the blood-brain barrier.
Whole-brain radiation therapy is often the only available therapeutic option for patients with multiple and larger
brain metastases. However, it is associated with potentially devastating side effects; therefore, there is an urgent
need to develop new targeted therapies. Stem cell-based therapies have the potential to fulfill this need. The
inherent tropism of neural stem cells (NSCs) towards solid and metastatic brain tumors after a local and systemic
injection has been demonstrated by multiple studies. This specific property, along with the low immunogenicity
of NSCs, has generated substantial interest in therapeutic applications using NSCs as carriers for targeted
delivery of anti-tumor therapies in experimental animal models and translation to clinical trials for patients with
glioblastoma. We have recently generated NSCs secreting therapeutic antibodies and tested NSCs' therapeutic
properties in a BM model in pre-clinical studies. However, there has been no reliable methodology to monitor
the intracranial behaviors of therapeutic NSCs in the complex in vivo brain environment. Therefore, it is
imperative to devise non-invasive imaging modalities for tracking NSCs in the brain to ensure the quality of
tailored development of NSC-based brain tumor therapies. Here, we propose to take advantage of a multimodal
imaging approach combining an integrated single-photon emission microscope (SPEM) and magnetic resonance
system that utilizes the inverted compound eye camera to track NSCs in the brain with high sensitivity and
resolution. We hypothesize that this multimodal imaging platform will generate well-validated pre-clinical data
necessary for successfully applying therapeutic NSCs to treat BM of breast cancer. The nanoparticle-based
approach developed in our laboratory will be utilized for cell labeling with imaging agents. Three interrelated aims
are designed to cover the scope of proposed studies. Specific Aim 1 will optimize SPEM/MR imaging for in vivo
tracking of NSCs within the brain parenchyma. Specific Aim 2 will investigate the migration of NSCs within the
brain of mice bearing BM using a multimodal imaging approach. Finally, Specific Aim 3 will investigate the
influence of whole-brain irradiation on the distribution of NSCs within the brain of mice bearing BM. This system
will provide an ultra-sensitive, non-invasive imaging platform for tracking NSCs in the pre-clinical model of BM
of breast cancer and can be widely applied for imaging stem cell behavior in the context of other brain
malignancies and solid tumors.

Public health relevance
PROJECT NARRATIVE The development of efficient neural stem cell-based therapies for treating brain metastases of breast cancer strictly depends on the knowledge of stem cell behavior in the complex brain environment. Therefore, this project will fully optimize the multimodal imaging platform and apply it to understand neural stem cell migration dynamics and distribution in several pre-clinical animal models of brain metastases.